Inter-Enzyme Crosstalk in the Cytochrome P450 Ensemble: Implications for the Effects of Alcohol on Drug Metabolism and Alcohol-Drug Interactions

The effect of alcohol consumption on drug metabolism and interactions of alcohol with drugs constitute a
significant health problem. The mechanisms of these effects are tightly related to the influence of alcohol on drug-
metabolizing system, and on cytochrome P450 ensemble in particular. Functional versatility of the cytochrome
P450 system is achieved through the presence of over a dozen of P450 species differing in their substrate
specificity. The composition of this ensemble is known to be largely affected by alcohol consumption. It is
generally presumed that the integral properties of this ensemble represent a simple aggregate of the properties
of the constituting P450 enzymes. Although this premise remains to be a foundation of rational analysis of the
routes of drug metabolism, its validity became essentially compromised. The body of evidence of system-wide
integration in the properties of the P450 ensemble continues to grow. The current project is prompted by
recognition of a far-reaching physiological significance and pharmacological importance of inter-species crosstalk
in the P450 ensemble and its thorough relevance to the effects of alcohol on drug metabolism and P450-
dependent cellular signaling.
Our central hypothesis is that the results of the alcohol-induced changes in the composition of the cytochrome
P450 pool are not limited to direct consequences of the activity of the alcohol-induced enzymes. They also
involve alterations of the metabolism of a broad range of exogenous and endogenous substrates of various P450
enzymes due to their interactions with alcohol-inducible P450 species. These indirect effects are deeply involved
in clinically-important cases of alcohol interactions with drugs and alcohol-induced alteration of cellular
signaling through eicosanoids, retinoic acid and other P450-dependent messengers.
This proposal is aimed to explore the alcohol-induced changes in P450 expression and their effects of on the
network of protein-protein interaction in the ER membranes and, consequently, on the system-wide properties
of the P450 ensemble. Our long-term goal is to obtain a complete picture of functional interactions between
human cytochromes P450, and the alcohol-inducible P450 species in particular, and characterize their role in
dictating the integral properties of the drug-metabolizing ensemble and their changes by alcohol consumption.
Specific Aims of the project are: (1) To refine our knowledge on alcohol-induced changes in the composition of
the cytochrome P450 ensemble in liver cells; (2) To identify the principal intermolecular interactions of alcohol-
induced P450 species in HLM; (3) To identify the major functional interactions of alcohol-inducible P450
enzymes with other P450 species and explore their effect on the metabolism of drugs and endogenous substrates
by the P450 ensemble. Fulfilling these aims will allow in-depth characterization of alcohol-induced changes in
drug-metabolism and P450-dependent cellular signaling and understand their role in deleterious alcohol-drug
interactions and other adverse effects of alcohol consumption.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it will provide a detailed picture of alcohol-induced changes in human drug-metabolizing ensemble and characterize system-wide changes in drug metabolism induced by alcohol exposure. The obtained knowledge will be instrumental for optimizing drug dozing regimes in alcohol consumers, and the drugs used in treatment of Alcohol Use Disorder and Alcohol Withdrawal Syndrome in particular. Besides providing new insights on the effects of alcohol on drug metabolism, this study will result in fundamental conceptual advancements in our understanding of complex cases of drug-drug and drug-alcohol interactions, adverse drug effects, and other alcohol-induced disorders with P450-dependent pathogenesis. Elaboration of the concept of function and regulation of the human drug-metabolizing ensemble as an integral multi-enzyme system, which is the long-term goal of our studies, is a matter of critical importance for in-depth understanding of the changes in human drug metabolism under influence of alcohol exposure and establishing a rational approach for optimal drug use under chronic alcohol exposure.